Lymph node regulation of metastatic fitness and reemergence

PROJECT SUMMARY
Metastasis is the most dangerous stage of cancer, responsible for the vast majority of breast cancer-related
deaths. Currently, we have no treatments that target metastasis; therefore, it is critical to understand
metastatic progression at the molecular, cellular, and tissue levels to develop therapeutic strategies against
this disease. This proposal investigates how the lymph node (LN) regulates tumor dormancy, a stage of
quiescence responsible for delayed relapse which affects ~20% of metastatic breast cancer patients. Using
this latency window as an opportunity for intervention requires an understanding of site-specific dormancy
regulation. Although the LN is the most common site of metastasis, very little is known about how it sustains
dormant DTCs and or what triggers reawakening. I hypothesize that stable LN endothelia deposit
quiescence factors which are lost when the stable niche is disturbed during inflammation. This proposal
combines animal studies, novel models of the LN microvascular niche (MVN), and intravital imaging to identify
LN molecules that contribute to DTC quiescence and reawakening. ECM proteomics identified candidate
quiescent factors including HSPG4, LOXL1, and TINAGL1 which will be validated in the LN MVNs. Candidates
will be functionally tested in the LN MVNs and in vivo. Further, acute inflammation will be used to trigger
dormant DTC reawakening in mouse models and by intravital imaging to see whether DTCs “wake up” when
their niche is activated. These studies will provide the first mechanistic understanding of how the LN promotes
tumor dormancy and demonstrate whether destabilizing the niche through inflammation is sufficient to wake
dormant tumor cells up. In the K00 phase, I propose to investigate route of dissemination as a selective force
that enriches metastasis-competent populations of tumor cells. Lymphatics are not only less hostile than blood
circulation, but present an opportunity for immune escape as LN LEC induce peripheral tolerance in the T cell
repertoire. LN LEC-mediated deletion of tumor-specific T cells27 may grant a survival advantage to lymph-
exposed DTCs, priming them for immune escape. Metastatic advantage of lymphatic dissemination will be
investigated using lymphatic-Cre transgenic mouse models to track dissemination route and metastatic
outcome, T cell receptor sequencing to elucidate the systemic effect of local deletion on the peripheral
repertoire, and molecular barcoding to track clonality and distribution of DTCs relative to their dissemination
route. Understanding how dissemination influences metastasis will help identify which tumor cells are most
likely to metastasize for elimination. The proposed aims will shed light on how the LN and lymphatic
dissemination instruct metastasis, revealing actionable targets against tumor dormancy and metastatic fitness,
provide invaluable experience studying the complex interactions between metastasis and immunity.

Public health relevance
PROJECT NARRATIVE This proposal aims to uncover lymph node-specific mechanisms that regulate tumor cell dormancy, reawakening, and immune escape. Unraveling microenvironmental regulation of tumor quiescence and outgrowth opens the possibly of clinically modulating tumor dormancy to prevent delayed relapse in the lymph node and elsewhere. Further, lymphatic dissemination may enrich for highly metastatic-competent tumor cell populations through generation of immune tolerance to lymph node-exposed tumor cells; understanding how this mechanism contributes to metastasis will uncover novel therapeutic strategies to identify and target tumor cell populations that are equipped to successfully metastasize.